Institutional Training in Otolaryngology Research

T32 Abstract
Rapid introduction of basic science discoveries into clinical fields requires close collaboration of basic and
clinician scientists. Accomplishing this in otolaryngology requires a multidisciplinary approach to better define
and treat the many disorders of the head and neck. Residency programs today offer limited research training
for otolaryngologists, but few become independent investigators. In contrast, the basic sciences postdoctoral
training offers little exposure to the clinical setting, making translational research difficult. The goal of this
application is to provide research training in otolaryngology and its related sciences. Support is requested for
in-depth training for 1) residents, 2) postdoctoral fellows, 3) predoctoral students and 4) short-term medical
students. All trainees will receive an interactive basic research experience with ongoing exposure to and
interaction of trainees in the clinical setting through conferences and courses. The pre- and postdoctoral
trainees will have a 24-month block of training. Research training for MDs will begin in medical school with
students doing short-term (3-month) projects and continue through the residency program with a 2-year block
midway through the clinical training. One resident will be admitted each year into this research track. Early
introduction and continued research involvement throughout the residency will increase our ability to attract
academically oriented faculty members into the field, with backgrounds to become independent investigators.
This cross-field exposure will enhance the experience for trainees and promote clinical and basic science
interactions as a faculty. A major strength of the program is drawing members of the faculty from a wide variety
of departments of the School of Medicine and across the UC campuses involved in otolaryngology related
research. This will enhance collaborative efforts in related fields of hearing, balance, smell, taste, speech,
language and head and neck cancer. All faculty members have primary or secondary appointments within the
Department of Otolaryngology, creating an ideal environment for translational research between basic and
clinician scientists. Through this multidisciplinary approach to research training for different levels of trainees
from a variety of fields, recruitment and retention of a research-oriented academic faculty involved in research
into disorders of the ears, nose and throat will be increased.

Public health relevance
T32 Narrative The goal of this application is to provide research training in otolaryngology and its related sciences. Support is requested for in-depth training for 1) residents, 2) postdoctoral fellows, 3) predoctoral students and 4) short- term medical students.